Upgrade of Bruker Time-domain EPR Spectrometer

This SIG (Shared Instrumentation Grant) project requests NIH funds for a major upgrade of an existing
and fully functional Bruker Biospin time domain E580 electron paramagnetic resonance (EPR)
spectrometer configured to operate at X- (9.5 GHz) and Q-band (34 GHz) resonance frequencies and
acquired back in 2009. The proposed upgrade will significantly expand capabilities of the existing
instrument for obtaining atomic-level details on the structural organization of catalytic metal centers in
enzymes, free radical intermediates of biochemical and photosynthetic processes, and structural
organization oligonucleotides, water soluble proteins, and membrane protein complexes. The specific
components of the proposed upgrades include adding (1) pulse-shaping and frequency chirping
capabilities enabled by AWG (arbitrary waveform generator) technology, (2) 300 W Q-band (34 GHz)
amplifier to achieve a further - up to 5.5-fold - increase in the excitation bandwidth, and (3) cryogen-free
variable temperature (5 K to 300 K) accessory to carry out these EPR experiments at optimal
temperatures and eliminate dependence on a non-renewable liquid Helium which short supply is creating
a major bottleneck in the research. The upgraded instrument will allow for carrying out time-domain EPR
experiments at lower protein concentrations, increase the distance range and improve accuracy of
longer-range distance constrains, and expand studies of protein systems and, particularly, membrane
protein complexes, we have currently major difficulties with because of the equipment limitations. These
capabilities will benefit a group if six Major and four Minor users from North Carolina State University and
other collaborating groups in North and South Carolina and the USA.

Public health relevance
Project Narrative The proposed major upgrade of the existing electron paramagnetic resonance spectrometer will improve sensitivity and significantly expand experimental capabilities at North Carolina State University and the Research Triangle area of North Carolina. The upgrades will improve throughput and enable new research carried out by a large group of investigators involved in studies of structure and function of proteins and their roles in disease, DNA repair mechanisms, development of new antifungals and antibiotics, and enzyme synthesis of new biologically active compounds. The upgraded instrument would also foster interdisciplinary collaborations in biomedical research.